Genetic determinants of Bacteroides vulgatus colonization fitness and host inflammatory responses

ABSTRACT
Bacteroides vulgatus (Bvu) is one of the most common members of the gut microbiota across diverse human
populations and has been strongly associated with multiple human diseases including the inflammatory bowel
diseases (IBD). However, there exist fundamental gaps in our understanding of the genetic and phenotypic
diversity within the Bvu species complex, as well as how Bvu strains mechanistically contribute to host
inflammatory phenotypes. Our long-term goal is to understand how gut microbes impact human health and
disease. Our preliminary studies in the human-derived Bvu strain CL09T03C04 identified putative genetic
determinants for Bvu fitness and competition in the mouse gut and also associated these genes with metabolites
identified by mass spectrometry. Using gnotobiotic mice, we have also established that different Bvu strains have
variable impacts on intestinal inflammation and immunity. These results and other diverse associations between
Bvu and gut inflammation in humans and animal models could be explained in part by genetic diversity among
Bvu strains. Yet, there remains a paucity of well-annotated genetic information associated with this species, and
strain-level variation across the Bvu species complex is almost completely unexplored. The objective of the
proposed research is to define the relationships between Bvu genetic variation with host inflammation and gut
microbial ecology. We will test the central hypothesis that Bvu uses distinct genetic and metabolic traits to
colonize the gut and modify host inflammation, and that the variable presence of those traits in Bvu strains
explains their divergent host responses. In Specific Aim 1, we will test the working hypothesis that regulation of
distinct lipid metabolites is required for in vivo survival and competition in Bvu strain CL09T03C04. In Specific
Aim 2, we will test the working hypotheses that the ability of different Bvu strains to promote or restrict gut
inflammation is mediated by distinct genetic traits, and that gut inflammation alters Bvu fitness. The expected
outcomes will vertically advance the field in several ways. First, they will provide the first in-depth understanding
of genetic and phenotypic diversity in the Bvu species complex, including identification of genes, pathways, and
metabolites responsible for Bvu’s ability to colonize the gut and to impact and adapt to gut inflammation. Second,
they will identify pro- and anti-inflammatory Bvu strains and affiliated mechanisms that may explain prior
association of the Bvu species complex with both exacerbation of and protection against IBD-associated
inflammation. These results are expected to have a positive impact because they could lead to the development
of new Bvu-directed prognostic markers and therapeutic approaches to modify gut microbial ecology and
inflammation, potentially improving diagnostic and therapeutic management of IBD and other human diseases.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the discovery of mechanisms by prevalent bacterial members of the human gut microbiome colonize the gut and regulate intestinal inflammation is expected to lead to new approaches for modifying microbiome composition and new treatments for the human inflammatory bowel diseases and other inflammatory disorders. The proposed research is therefore relevant to the part of NIH’s mission that pertains to developing fundamental new knowledge that will enhance health and reduce the burdens of illness.